Client and clinician priorities for same-day PrEP and DoxyPEP awareness, uptake, and persistence in primary care.

PROJECT SUMMARY/ABSTRACT
Approximately 70% of all new human immunodeficiency virus (HIV) infections are among populations of sexual
and gender minorities (SGM) and are primarily attributable to sexual contact.1 Currently only 26% of the U.S.
population who would benefit from HIV preexposure prophylaxis (PrEP) are prescribed this effective
biomedical HIV prevention strategy2 that would help achieve the “Ending the HIV Epidemic” (EHE) goals that
targets a 90% reduction in new HIV infections by 20303. Biomedical prevention strategies for bacterial sexually
transmitted infections (STI) like doxycycline postexposure prophylaxis (DoxyPEP) are a vital component to the
successes EHE given the well-known association between STIs and risk for HIV infection4,5. Increases in
biomedical prevention depend on the individual and interpersonal factors of the clients accessing care and the
clinicians who provide the care6. Understanding these, and numerous other potential factors specific to
community and society may better inform the approach to HIV and STI biomedical prevention strategies in the
primary care setting. In this mixed methods study, we will leverage group concept mapping and conduct focus
groups with identified stakeholder groups (e.g., SGM clients and primary care clinicians) to (1) Describe
approaches from SGM client perspectives that facilitate awareness, uptake, and persistence of biomedical
prevention (same day PrEP & DoxyPEP) in the primary care setting, (2) describe approaches from primary
care clinician perspectives that facilitate awareness, uptake, and persistence of biomedical prevention (same
day PrEP & DoxyPEP) in the primary care setting and (3) identify the joint priorities of clients and clinicians
(high-feasibility and high-importance) for the integration of same day PrEP and DoxyPEP in primary care.
Clients and clinicians have a wealth of knowledge and experience and can provide unique perspectives
specific to factors influencing HIV and STI biomedical prevention awareness, uptake, and persistence.
Findings will inform the development of culturally appropriate interventions to improve the HIV and STI
biomedical prevention strategies in the primary care setting. The proposed research and training plan aligns
with the National Institute of Nursing Research Strategic Plan on health equity, systems and models of care,
prevention/promotion, and population health. The proposed study builds on the applicant’s knowledge of health
equity and disparities, improvement in biomedical HIV and STI prevention, and mixed methods approaches.
Training will focus on developing proficiency in mixed methods, building expertise in SGM-affirming health and
healthcare approaches for vulnerable populations, and advance the scientific understanding of HIV and STI
prevention within sexual and gender minorities through scholarly writing and the dissemination of research
findings. The training plan and mentorship team will prepare the applicant for a career as an independent
researcher conducting rigorous mixed methods research on health inequity and HIV/STI disparities among
SGM.

Public health relevance
PROJECT NARRATIVE Populations of sexual and gender minorities (SGM) are disproportionally impacted by higher rates of human immunodeficiency virus (HIV) and other sexually transmitted infections (STIs). Effective biomedical prevention, such as same day preexposure prophylaxis (PrEP) and doxycycline postexposure prophylaxis (DoxyPEP), are effective strategies to reduce rates of both HIV and other STIs; however, their use in the primary care setting have not been widely explored. This study aims to leverage key stakeholder (e.g., SGM client and primary care clinicians) perspectives to identify factors influencing awareness, uptake, and persistence of same day PrEP and DoxyPEP in the primary care setting.